Ultra-sensitive multi-mode laser-scanning imaging system

SUMMARY This proposal request funds to acquire an ultrasensitive highly quantitative imaging platform suitable for quantification of fluorescent, chemiluminescent, chromatic, and radioactive signals on gels, histologic slides, well plates, and phosphor imaging cassettes for radioactivity. This application will directly support 12 NIH- funded investigators and support and substantially expand the research supported by 24 NIH grants. Each of these investigators has specific projects that benefits from one or more unique aspects of the Cytiva Typhoon 5 laser-scanning imager. In some cases, the experiments involve ultrasensitive quantification enabling protein detection from exceptionally low input samples. In other instances, the Typhoon 5 enables increased throughput and broadens the capacity for screening and discovery. In other cases, the experiments enable quantification of radioactive signals, which is no longer available at the Weill Cornell Imaging Core facility. The Typhoon 5 is intended to replace a nonfunctional phosphor imager. The Typhoon 5 will provide capabilities to Weill Cornell Medicine and neighboring institutions and will be supervised by an advisory committee, overseen by the Pharmacology Core, and will thus positively impact basic and translational NIH-funded research, expanding chemical biology, chemical biology, and pharmacology research. The NIH-funded research programs supported by this instrumentation has relevance to cancer, immunology, metabolism, drugs of abuse including alcohol, neuroscience, neurodegeneration, bone disease, and other pathways.

Public health relevance
NARRATIVE One of the most essential and fundamental requirements for performing basic science research is to be able to perform accurate quantification, including quantification of proteins and small molecules. In this application, we propose acquiring a state-of-the-art laser scanning instrument that provide unprecedented sensitivity and dynamic range in quantification of proteins, small molecules, and other biomolecules using fluorescence, chemiluminescence, absorbance densitometry, or radioactivity. This work will fundamentally advance the throughput, impact, and accuracy of a group of NIH-funded research projects at Weill Cornell Medicine and neighboring institutions.